CE24-001, Injury and Violence Prevention Center at the University of Colorado Anschutz Medical Campus

ABSTRACT
The Mountain West region experiences a higher burden of injury mortality than many other parts of the nation
and the region includes significant populations including rural and frontier populations, Latinos, American
Indians, Veterans, and uninsured individuals. The Injury and Violence Prevention Center (IVPC) at the
University of Colorado Anschutz Medical Campus was established with the vision of contributing to the
significant reduction in injury and its outcomes in Colorado, the Mountain West region, the U.S., as a function
of high-quality research, education, and effective practice. We seek to accomplish this with three specific aims
(1) Nurture cutting-edge prevention-focused research on injury and violence that responds to and guides
practice in regional and national contexts; (2) Enhance skills of the current and future injury prevention
workforce, engage related professionals and trainees across disciplines, and increase awareness of prevention
strategies, and (3) Provide leadership in addressing injury problems by working with community members,
practitioners, and policy makers. We will achieve these aims through objectives and activities organized into 3
cores: Administrative Core, Outreach Core, and Training and Education Core. As we work toward these aims,
and our mission of driving evidence-based practice through research, education, training, and practice, we
affirm these core values: (1) Advancing Health Equity; (2) Ethical Research and Practice; (3) Translation of
Research to Practice, and (4) Collective Impact. The four proposed research projects address research
priorities for the National Center for Injury Prevention and Control. As part of an established partnership
working to address substance use and adverse childhood experiences (ACE’s), Project 1 will use a community-
based approach to identify the social determinants of health- and substance use disorder-related needs of a
rural, largely Latino community in Colorado. Project 2 will use a randomized control trial design to test
messages to prevent firearm suicide among Veterans. Project 3 will identify social and structural level factors of
suicidal ideation for Black girls and young women to inform and develop effective suicide prevention efforts.
Project 4 will use an innovative methodological approach, and a nationally representative sample, to
understand parents’ decisions regarding their children’s contact and/or collision sports participation. We are
uniquely well-positioned to provide leadership in the region and nationally. We will build on our solid foundation
of a team of nationally and internationally recognized injury prevention leaders and researchers and strong
collaborative relationships with practice partners.

Public health relevance
Narrative The Mountain West region experiences a higher burden of injury mortality than many other parts of the nation and includes significant vulnerable populations. The Injury and Violence Prevention Center at the University of Colorado Anschutz Medical Campus aims to reduce injury and its outcomes in the Mountain West as a function of high-quality research, training and education, and translating research into practice and policy. We will provide leadership in the region, and nationally, through our team of nationally recognized experts and strong collaborative relationships with practice partners.